Mechanism of the telomeric proliferation limit

This long-term project is focused on replicative senescence, the process whereby telomere shortening limits
the proliferation of human cells. In the past, our work on this project showed how telomeres are protected by
shelterin and how loss of shelterin-mediated protection can induce senescence. Recently, we have focused
more narrowly on aspects of telomere biology specifically relevant to replicative senescence of primary human
cells. Our preliminary data has revealed that replicative senescence is induced by the activation of the ATM
(not ATR) kinase at critically-short telomeres that have become deprotected because they lack sufficient TRF2.
Furthermore, we have addressed the question of why cells grown at 3% (physiological) oxygen levels show an
extended replicative life span compared to cultures in normoxia. In both conditions, ATM inhibition (ATMi) or
overexpression of TRF2 resulted in life-span extension. Life-span extension at 3% oxygen was not due to a
difference in telomere shortening rates or altered expression of TRF2 or ATM pathway factors. Instead, we
found that the ATM kinase is less responsive to DSBs and damaged telomeres at 3% oxygen, leading to a
greater tolerance for short telomeres and an extension of replicative life span. These observations form the
basis for AIM 1, which is focused on further defining the mechanisms of proliferative senescence,
understanding how ATM is regulated by oxygen levels, and determining what aspect of TRF2-mediated
protection is lacking at critically-short telomeres.
As part of our long-term interest in understanding how TRF2 protects telomeres, we have obtained
preliminary data that formation of the t-loop, which represses ATM signaling, involves tetramerization of TRF2.
We found that TRF2 binds to telomeric DNA as a tetramer whereas its paralog TRF1, which does not protect
telomeres, binds as a dimer. A dimeric form of TRF2 is defective in telomere protection but could be partially
restored by enforced tetramerization. Furthermore, an engineered TRF1 tetramer formed t-loops and protected
telomeres in vivo. In AIM 2, we will further test the model that t-loop formation requires TRF2 tetramers.
We recently reported that the highly conserved iDDR domain of TRF2, which binds to the Rad50
subunit of the Mre11/Rad50/Nbs1 (MRN) complex, prevents MRN from associating with CtIP and thus blocks it
from becoming an active endonuclease. Interestingly, the iDDR is functionally (but not structurally) similar to
MRN inhibitory modules in yeast telomeric proteins, pointing to convergent evolution. Our preliminary data
suggest that the iDDR also interferes with the ability of MRN to active the ATM kinase. In AIM 3, we will
determine the mechanism of ATM inhibition and explore the physiological role of the iDDR, seeking to explain
its evolutionary conservation.
Together, these experiments will provide insights into the ATM kinase, its regulation, and its repression
by TRF2, revealing mechanistic insights into how shortening telomeres limit the proliferation of human cells.

Public health relevance
PROJECT NARRATIVE Programmed telomere shortening limits the proliferation of normal human cells by inducing replicative senescence. Although replicative senescence is a central aspect of aging biology, many aspects of this process are not understood. This project aims to reveal the mechanisms underlying replicative senescence.